Guide RNA Binding Complex

SUMMARY
Parasitic infections caused by Trypanosoma brucei spp. have historically undermined public health and
economies in Sub-Saharan Africa, only partially curtailed by recently approved therapeutics. Although the long-
term impact of repurposed drugs remains unclear, sustained research has positioned T. brucei among the most
prolific unicellular model systems. Paradigms of antigenic variation, GPI-anchoring, RNA interference, and others
have critically informed eukaryotic biology, while discoveries of RNA editing and guide RNAs (gRNAs) have
translated into genome and transcriptome-altering technologies. The trypanosomal mitochondrial editosome
consists of interacting RNA binding and enzymatic modalities. RNA editing substrate binding complexes
(RESCs) enclose gRNAs and mRNAs, initiating editing by scaffolding their imperfect hybrid. RNA editing catalytic
complexes (RECCs) recognize mismatches in the hybrid as editing sites and execute mRNA cleavage, uridine
insertion or deletion, and re-ligation reactions. A principal auxiliary factor, DEAH-box RNA helicase KREH2, likely
contributes to editing progression, although the mechanism remains unclear. Empowered by our recent
advances in cryogenic electron microscopy (cryoEM) of mitochondrial ribonucleoproteins and macromolecular
enzymes, we propose visualizing the editing pathway by determining RESC structures at discernible steps.
Through charting protein composition, interactions, and RNA occupancy, we will define the functions of distinct
RESCs and determine their structures by cryoEM. Genetic and reconstitution approaches will validate structural
predictions and align RESC remodeling and editing events.
Aim 1 investigates RESCs that bind gRNA and pre-mRNA to initiate and monitor editing and evict gRNA upon
completion. We have discovered and characterized commensurate RESC states. We will solve their structures,
identify RNA cargo and interactions, and reconstitute proteinaceous components in a heterologous host.
Aim 2 examines KREH2 helicase as the putative ATP-dependent molecular motor driving the editing pathway
by remodeling RESCs. We hypothesize that KREH2 recognizes the gRNA’s 3′ end and disassembles RESCs
by translocating the gRNA 5′-bound to RESC2 pseudo-triphosphatase. By modulating KREH2 and RESC2
activities, we will interrogate RESC permutations and concomitant RNA dynamics.

Public health relevance
PROJECT NARRATIVE We aim to understand how different structural states of the RNA editing substrate binding complex (RESC) facilitate specific mechanistic steps during the editing of mitochondrial mRNAs in Trypanosoma brucei, the parasite responsible for severe tropical diseases. Since RNA editing is crucial for the parasite’s survival, our research will enhance fundamental knowledge about this medically and economically significant pathogen.